AROUSAL THRESHOLD TO AUDITORY STIMULATION DURING SLEEP IN CHILDREN

Patients are recruited from those referred to Pediatric Sleep Disorders Clinic for evaluation of clinically suspected OSAS. Patients will be eligible if they have a history of snoring, and have no other medical disease. All patients will undergo an 8-hour overnight sleep study. This is a routine medical care for patients with symptoms of OSAS, and is standard for diagnosis. The patients with adnotonsillar hypertrophy & polysomnography compatible to OSAS will be eligible for the study. Age-matched healthy children from the general population will perform a similar polysomnography to document normal breathing. These children will be recruited from the general population by advertisement.